Host Response to Hepatitis Delta Virus Infection

Abstract
Hepatitis delta virus (HDV) is a satellite virus of hepatitis B virus (HBV); thus, infection occurs only in
individuals with concurrent HBV infection. Currently, more than 35 million people worldwide are persistently
coinfected with HBV-HDV. Coinfection with HDV substantially exacerbates liver inflammation, accelerating the
progression to end-stage liver disease (ESLD) within 5-10 years, whereas HBV mono-infection typically requires
40 years to develop ESLD. Currently, no effective therapy is available, presenting a significant public health
threat. To mitigate the disease burden, elucidating the mechanisms underlying HDV pathogenesis is imperative.
Melanoma Differentiation-Associated Gene 5 (MDA5), a pattern recognition receptor (PRR), is thought
to play a central role in recognizing HDV infection. Our genetic, biochemical, and signaling studies reveal that
HDV infection of human hepatocytes produces viral RNA species that act as pathogen-associated molecular
patterns (PAMPs), resulting in a potent activation of MDA5 signaling. This event promotes a robust and
constitutive induction of over 300 antiviral genes, namely interferon-stimulated genes (ISGs).
Despite the strong activation of the hepatic IFN system, which is expected to repress the viral lifecycle,
our study found that HDV displays significant resistance to the antiviral properties of ISGs. Furthermore, one of
the ISGs, adenosine deaminase acting on RNA 1 (ADAR1), is indispensable for the HDV lifecycle as it introduces
a site-specific viral genome mutation necessary for producing two viral protein isoforms—small- and large-
hepatitis delta antigen—that regulate genome replication and virion assembly, respectively. These findings
suggest that MDA5 signaling functions as a proviral, rather than an antiviral, host factor in HDV infection,
challenging the existing paradigm. Moreover, our transcriptome analysis and polysome profiling suggest that the
constitutive and potent ISGs induction by HDV leads to the activation of programmed cell death through their
protein translation inhibition properties. These observations form the basis of our central hypothesis: “HDV
exploits the ISGs induction pathway to sustain its viral lifecycle, while simultaneously mediating pathogenesis
through the activation of programmed cell death”.
Accordingly, this exploratory proposal is designed to elucidate the mechanism and significance of the
viral innate immune evasion program as the critical pathophysiology of HDV infection through the following
specific aims: Aim 1: Determine the proviral role of MDA5 signaling in HDV infection and Aim 2: Define the
mechanism of HDV infection-induced hepatocyte-intrinsic programmed cell death. Both aims are centered
around the host response to HDV infection, in particular the robust and persistent induction of ISGs. The
successful completion of the proposed studies will provide novel insights that aid knowledge gaps in our
understanding of HDV pathogenesis and provide the framework for future investigations with in vivo models as
well as clinical specimens, ultimately leading to the development of novel therapeutic strategies.

Public health relevance
Public Health Statement/Project Narrative Hepatitis Delta Virus (HDV) infection promotes rapid disease progression towards the development of end-stage liver disease, and currently, there exists no effective antiviral strategy. This proposal will investigate the interplay between HDV and the antiviral defense program of human hepatocytes that underlies the pathogenesis. The insights gleaned through this study will reveal novel targets for the development of anti-HDV therapeutics.